Interrogating neurogenic defects in complex assembloid models of fragile X syndrome

PROJECT SUMMARY/ABSTRACT
Human neural development is a dynamic process that requires a precise orchestration of a sequence of cellular,
molecular and genetic events allowing for the establishment of appropriate neural circuitry and functional
connectivity in the brain. Disruptions to this process have profound consequences, and several
neurodevelopmental disorders converge on molecular pathways that regulate protein synthesis, proliferation,
migration and differentiation in neural cells. One such disorder is Fragile X syndrome (FXS), which is the leading
form of inherited intellectual disability and the most common monogenic cause of autism. Transcriptional
silencing of FMR1 and subsequent loss of the RNA-binding protein FMRP leads to altered proliferation,
dysregulated protein synthesis, and disrupted signal transduction in animal models of FXS; however, the
consequence of loss of FMRP on early events in neurogenesis in humans remains relatively unknown. While
several highly promising preclinical studies have demonstrated that targeting key signaling pathways ameliorates
multiple defects in animal models, most of these have not translated into successful human therapeutic
interventions. We believe that a major gap in the preclinical phase may have been the lack of a human neuronal
model to test drug efficacy in a developmentally-relevant manner. Recently, a phase 2 clinical trial using a
phosphodiesterase inhibitor to inhibit degradation of cyclic adenosine monophosphate (cAMP) in FXS patients
showed highly promising results on several outcome measures. This proposal aims to provide a novel human
cellular platform with robust cellular and molecular readouts to further test the efficacy of therapeutic
interventions. Here, we propose to use 3D organoids to determine whether cAMP signaling is disrupted
throughout early brain development in FXS, and whether aberrant cAMP signaling underlies defects in
neurogenesis and cell fate commitment. We will also investigate the therapeutic potential of targeting the
microtubule-associated protein doublecortin (DCX), which is an mRNA target of FMRP as well as a downstream
target of the cAMP intracellular cascade (Aim 1). We will further employ a novel assembloid system to study cell
fate commitment of excitatory and inhibitory neurons as well as interneuron migration in FXS, and to determine
the contribution of altered DCX expression and cAMP signaling to interneuron development and differentiation
(Aim 2). These findings will provide critical insight into the underlying pathomechanisms in FXS, as well as into
the biology of FMRP during early human development. Ultimately, this may aid in the development of targeted
patient-specific therapeutic strategies that have broader implications for other neurodevelopmental disorders.

Public health relevance
PROJECT NARRATIVE Despite several highly promising preclinical studies in animal models of fragile X syndrome (FXS), we lack a viable treatment for patients. This research aims to provide novel mechanistic and functional insight into altered cyclic adenosine monophosphate (cAMP) signaling and downstream targets across early brain development in human cellular models of FXS. We propose to use 3D organoids and dorsal-ventral assembloids to investigate defects in signaling, neurogenesis, cell fate commitment and interneuron development in FXS.